Cortical Alpha-Synuclein in Dementia

Abstract
Lewy-Body dementias, including Parkinson’s disease Dementia and Dementia with Lewy Bodies, are
devastating, multi-system diseases and a major cause of dementia worldwide. Patients have characteristic
symptoms that suggest dysfunction of the frontal-network, including difficulty with planning, fluctuating attention
and impaired flexible learning. The pathology of patients with dementia includes widespread aggregates of the
protein alpha-synuclein (𝛼-syn) in the frontal cortex and other extra-nigral regions. Despite this association, the
role of 𝛼-syn pathology beyond the dopaminergic system remains unclear. There is a critical need to
understand how -syn affects network function to develop treatments for Lewy Body dementias.
Our long-term goal is to develop treatments for Lewy Body Dementia by targeting circuit-level dysfunction. Our
overall hypothesis is that local -syn aggregation in the cortex disrupts prefrontal circuits, leading to executive
dysfunction. Testing this overall hypothesis requires determining the regional effect of 𝛼-syn on cellular activity
and neuronal plasticity in isolation from deficits secondary to other major neurotransmitter systems that project
to cortex. To accomplish this goal, this proposal uses viral overexpression of -syn localized to the prefrontal
cortex. By imaging the activity of individual neurons and the plasticity of dendritic spines, we can learn how
cortical cells respond to this enigmatic, disease-associated protein. We propose to use 2-photon transcranial
microscopy to determine how neuronal activity (Aim 1) and synaptic plasticity (Aim 2) respond to regional
overexpression of -syn over the course of aging. In Aim 3, we will use a rule-learning, reversal and rule-
shifting tasks adapted for head-fixed applications to determine how prefrontal-dependent learning and flexibility
respond to cortical -syn. In parallel, we will correlate cognitive performance with anatomical plasticity and
neuronal activity. Findings from this proposed research will provide targets for future studies to restore cortical
function and treat symptoms through circuit-level manipulation. In addition, by comparing outcomes across the
three aims, we will be able to connect structural plasticity, neuronal activity and frontal-cognitive behavior to
provide broad insights into the prefrontal cortex.

Public health relevance
Project Narrative: Parkinson’s Disease Dementia and Dementia with Lewy Bodies are defined by aggregates of the protein alpha-synuclein. Patients have impairments in functions associated with the prefrontal cortex, such as attention, planning and flexible learning. This proposal will determine how alpha-synuclein pathology affects cortical neurons and activity, providing potential targets to restore cortical function.